Development and Translation of Hyperpolarized C-13 Prostate Cancer MRI Methods

Project Summary/Abstract
This Bioengineering Research Partnership has been designed to develop new techniques to perform primary
and especially metastatic prostate cancer patient HP 13C MRI exams with the goal of creating a robust, reliable
exam with 2-fold higher SNR, 5-fold higher spatial coverage, and new metabolic information from C-2 pyruvate
to benefit prostate cancer research, clinical trials evaluating new treatments, and ultimately patient care.
Preliminary studies have demonstrated the ability of dynamic HP 13C MR to detect upregulated LDH-catalyzed
pyruvate to lactate conversion in aggressive prostate cancers and also to measure a dramatic reduction following
successful therapy. While “proof-of-principle” has been shown in these initial studies, new bioengineering
developments, hardware, and software are required to create a robust, cost-effective HP 13C MRI exam to fulfill
clinical unmet needs. The current techniques are not robust, well-characterized tools ready to be widely applied.
This BRP, with its specialized multidisciplinary research team, is designed to accomplish the required
bioengineering developments and patient clinical research needed to refine, test and disseminate these new
techniques & hardware following the NIH guidelines for scientific rigor, transparency and reproducibility.
Specifically, we aim to: 1) Improve HP Pharmacy Methods for Producing Sterile HP 13C-pyruvate; 2) Develop
New Robust HP 13C MR Technology for Primary Prostate Cancer; and 3) Specific Technical Developments for
Metastatic Prostate Cancer Exam. New robust acquisition and analysis techniques will be developed and tested
in pre-prostatectomy patients with the correlation of kPL & kPG conversion rate constants to step-section
histopathology as the gold standard. Also the new methods will be applied in studies of patients with metastases
to lymph nodes and pelvic bone to investigate their ability to detect therapy response/resistance for individual
patients and future clinical trials of emerging pharmaceutical strategies. While focused on prostate cancer, the
proposed BRP aims to develop new HP 13C metabolic imaging techniques that will ultimately benefit the clinical
management of a wide variety of diseases. All techniques, hardware designs, pharmacy methods, open-source
software, and anonymized patient data from this BRP project will be disseminated to all interested sites
continuing this BRP’s active dissemination methods to over 20 sites thus far in order to accelerate the tempo
and improve the clinical impact of this powerful molecular imaging approach.

Public health relevance
PROJECT NARRATIVE The goal of this Bioengineering Research Partnership project (with partners/collaborators at Stanford, MD Anderson, UCB, UFlorida, GE & Isotec) is to develop new techniques and test them through early-phase studies in primary and metastatic prostate cancer to create the most reliable, cost-effective, high quality HP C- 13 MRI exams possible to benefit individual patients and future clinical trials. While this project focuses on prostate cancer, these bioengineering developments are designed to be generally applicable to human HP MRI studies benefiting a broad variety of studies.